Brain Aging in Adults with Autism Spectrum Disorder

The goal of my F31 Predoctoral Fellowship application is to receive integrated multidisciplinary training in cellular
and molecular neurobiology and immunology toward establishing my future independent research career at the
critical intersection of neurodevelopmental disorders and aging. Neurodevelopmental disorders are most
commonly studied in childhood and adolescence, however the challenges associated with aging for the nearly 6
million adults in the United States currently living with autism spectrum disorder (ASD) remain largely unexplored.
Decades of research reveal that the brains of children with ASD undergo an altered growth trajectory
characterized by excess brain volume, neuron density, and connectivity. Although comparatively little is known
about the course of brain development throughout adulthood in ASD, alterations are characterized by cell, spine,
and myelin loss –signaling an increased risk of developing age-related cognitive impairments. Chronic
neuroimmune activation in ASD throughout development provides a plausible mechanism for increased
vulnerability to age-related processes. My dissertation explores part of an overarching framework that early
excess brain growth, local hyper-connectivity, and imbalanced neuronal signaling triggers a cycle of
neuroinflammatory responses and cell damage contributing to neuropathogenic processes into adulthood. With
my outstanding mentorship team, I propose to characterize age-related changes in neuroimmune profiles (Aim
1), immune cell phenotypes (Aim 2), and neuronal inflammation (Aim 3) throughout adulthood. I will use
postmortem human brain tissue from individuals with ASD and unaffected controls 20-70 years of age and target
regions related to core socioemotional deficits, the amygdala and superior temporal gyrus (STG), and the
hippocampal formation, a region principally implicated in aging. I have unique access to an extensive collection
of clinically and genetically well characterized postmortem human brains through our tissue collection program.
Through my dissertation research, I will receive training in novel, cutting edge methods on human tissue including
single molecule fluorescence in situ hybridization (smFISH) HiPlex RNAscope to spatially map within-cell
transcriptomic profiles. With these findings, we can begin to identify cellular and molecular phenotypes most
vulnerable to pathological aging and windows for intervention to promote healthy aging in the rapidly growing
population of autistic adults.

Public health relevance
PROJECT NARRATIVE Nearly 6 million adults in the United States live with socioemotional and neurobiological challenges associated with autism spectrum disorder (ASD). Although differences in brain and behavior are well documented in children with ASD, little is known about the trajectory of brain aging across the lifespan. The objective of this study is to identify age-related changes in neuroimmune processes in autistic adults that may be indicative of atypical and potentially accelerated brain aging.